Development Core

DEVELOPMENTAL CORE: PROJECT SUMMARY/ABSTRACT
The overall goal of the Developmental Core (DC) of the Southern California Center for Children’s Environmental
Health Translational Research (SC-CCEHTR) is (1) to nurture and mentor junior investigators developing new
translational research strategies and approaches to children’s environmental health science (CEHS), and (2) to
develop a Catalyst Project Program addressing time-sensitive or emerging challenges in CEHS and testing novel
multidisciplinary translational approaches to identify the causes and reduce the burden of environmental disease.
A Career Development Program (CDP) will develop CEHS expertise and identify and promote training
opportunities that are concordant with the Center theme of Urbanism, Air Pollution, Children’s Health and
Environmental Justice. The CDP will distinguish itself by promoting integration across diverse fields largely
new to CEHS, including communication, policy and urban design, sociology, dramatic arts, education, network
analysis and implementation science, among others; and traditional CEHS population sciences. Junior
investigators will be supported by Catalyst Program pilot project funds with a goal of increasing CEHS
translational impact, productivity, competitiveness for peer-reviewed external funding in CEHS, and progress to
research independence. An innovative CD Seminar, a forum for mentoring, especially peer mentoring,
information exchange and development of new interdisciplinary translational teams, will help promote integration
across disciplines. Center enrichment activities, including Center seminar series, workshops, associated visiting
scientist symposia, Focus Area working groups, yearly Center retreats, and travel support will all have a focus
on junior investigators’ CD. An innovative partnership with the International Society for Children’s Health and the
Environment (ISCHE) will expand the reach of the CDP. ISCHE will train junior investigator “Fellows” in policy,
science communication and community science. The Center will support travel of approximately 10 ISCHE
Fellows and participants in the SC-CCEHTR CDP who are ISCHE members to an ISCHE Retreat in Years 3 and
5. Fostering interactions with junior investigators from other institutions regionally and across the country will be
a Center priority. External investigators from ISCHE, other Children's Environmental Health Research
Translation Centers, and other partners will have priority for the Catalyst Program pilot projects and Center CD
resources in order to promote mutually beneficial collaboration. The DC will also leverage a broad spectrum of
training opportunities developed across three other NIEHS-funded centers at USC, focused on CEHS, that have
a track record of successfully mentoring junior faculty to independence and tenure-track faculty positions. The
DC will be a model for promoting better understanding of CEHS that leads to reduced air pollution exposure and
healthier communities.